2/7 Psychiatric Genomics Consortium: Finding Actionable Variation

ABSTRACT The Psychiatric Genomics Consortium aims to aggregate and analyze genetic data to advance our understanding of psychiatric disorders. The continued success of the PGC has seen the scale of the project increase as we attract more collaborators and expand to study a wider range of psychiatric disorders. With this growth we see the need for the appointment of a new position, the Data Intake Officer (DIO).

Public health relevance
Narrative By appointing a dedicated person (Data Intake Officer) to be responsible for this entire process of sample intake and integration, we will improve the efficiency of PGC operations and ultimately enable more rapid and seamless genetic data science.